Oxidative Lipidomics in Pediatric Traumatic Brain Injury

Each year in the US, severe TBI in children results in ∼7400 deaths and 60 000 hospitalizations. Fifty percent
of surviving children with severe TBI have poor neurological outcome at six months. Severe TBI in children is
thus a critical problem in desperate need of impactful therapies. Free radicals and oxidative stress have been
uniformly accepted as universal pathogenic mechanisms of TBI prompting therapeutic use of antioxidants.
Invariably, clinical trials of non-specific free radical scavengers/antioxidants failed. This suggests that true
sources and mechanisms of TBI redox disbalance remain undefined, and represent a potential therapeutic
opportunity. During the previous funding period we showed that lipid peroxidation after TBI in immature brain
occurs as a result of controlled enzymatic reactions. We discovered that peroxidation of mitochondrial
phospholipid cardiolipin (CL) represents a required stage of neuronal apoptosis after TBI in postnatal day
(PND) 17 rats. We identified cytochrome c as a catalyst of CL peroxidation and showed that a mitochondria-
targeted inhibitor of CL peroxidation suppressed TBI-induced apoptosis and preserved cognitive function in
PND17 rats. Our latest work identified highly selective oxidation of arachidonic acid (AA) containing
phosphatidylethanolamines (PE) by 15 lipoxygenase (15LOX) to be causative to ferroptosis. We discovered
that PE binding protein 1 (PEBP1) complexes with 15LOX and changes its substrate specificity from free AA to
AA esterified into PE to generate hydroperoxy-AA-PE death signals. Normally hydroperoxy-AA-PE are
eliminated by combined action of glutathione peroxidase 4 (GPX4)/glutathione (GSH). Immature brain has
lower GSH levels and GPX activity vs adult brain thus could be more vulnerable to ferroptosis upon injury.
Indeed our preliminary data show that TBI leads to marked increase in expression and activity of 15LOX, and
accumulation of oxidized AA-PE in PND17 rat brain. Furthermore, preliminary data indicate that inhibition of
AA-PE oxidation suppresses TBI-induced neuronal death and preserves cognitive function. Thus, we
hypothesize that generation of oxidized AA-PE by 15LOX/PEBP1 complex leads to neuronal death and
represents a new target for drug discovery leading to innovative therapies in pediatric TBI. We propose to test
our hypothesis in three Specific Aims. Aim 1 will determine the degree, spatial and temporal pattern of
15LOX/PEBP1 complex formation and AA-PE oxidation after TBI. Aim 2 will investigate the mechanisms of
AA-PE oxidation in TBI-induced neuronal death. Aim 3 will design and investigate the mechanism of action and
neuroprotective potential of small-molecule regulators of 15LOX and 15LOX/PEBP1 activity in TBI. These
studies will employ powerful lipidomics and oxidative lipidomics technology to provide important mechanistic
information on the role of PE oxidation in neuronal ferroptosis after pediatric TBI. The ability to selectively
modulate PE oxidation, a critical early event in the mechanism of ferroptosis, could lead to targeted therapies
for TBI and ultimately improve outcome for children after brain injury.

Public health relevance
Trauma is the leading cause of death in children. Severe traumatic brain injury (TBI) is the most important component of this mortality and associated morbidity. A specific therapy for TBI does not yet exist and standard treatment remains supportive in nature. This project will identify role of oxidized phospholipids in neuronal death after pediatric TBI using state of the art oxidative lipidomics approach. We will test novel therapeutic compounds in experiments to prevent neuronal death, improve outcome after pediatric TBI. The ability to selectively modulate this pathway could lead to targeted therapies for TBI and ultimately improve outcome for children.